Wearable Graphene Respiratory Sensor for Early Detection and Monitoring of Asthma

Project Summary / Abstract
Asthma is a chronic, non-communicable disease that affects 300 million children and adults worldwide. In the
United States alone, asthma burdens 26 million citizens. With the rise of global temperatures, climate change is
adding to the complexity of asthma occurrences. Changes in environmental conditions can lead to negative
downstream effects such as prolonged pollen seasons that can elevate aeroallergens. Increase in aeroallergens
are concerning due to its association to allergen-induced asthma. Asthma is a debilitating disease that has no
cure, and the severity of the disease varies person to person. Diagnosis and monitoring in children is challenging
due to an inability to follow technical instructions to perform lung functioning tests such as spirometry and their
inability to communicate symptoms. To alleviate difficulties associated with diagnosis and monitoring of asthma
treatments in children, Aquillius Corporation proposes to develop a respiratory sensor capable of real-time
continuous monitoring and measuring of pulmonary functions. Utilizing graphene nanotechnology, this innovative
device will be cost-effective, robust, and suitable for all ages. Our approach seeks to improve patient monitoring,
treatment, and diagnosis of asthma through development of innovative respiratory sensor. To reach this goal,
Aquillius will (i) Optimization of respiratory sensor’s function by utilizing a manikin lung simulator for normal and
asthma conditions; and (ii) Demonstrate the ability of GNS respiratory sensor to capture pulmonary function data
in real time. Upon the successful completion of Phase I feasibility studies, Phase II will focus on development
and refinement of the device by incorporating human test subjects with asthma. The end-user interface and
software will also be further developed. Overall, the commercialization of the respiratory sensor will greatly
improve patient care by measuring a patient’s lung function in real-time, thus helping with both accurate diagnosis
and personalized asthma treatments.

Public health relevance
Project Narrative Climate change and environmental pollutants have been identified as major contributors to rising asthma rates, which already affects over 300 million people globally. Asthma diagnosis is particularly difficult in children and current methods are not optimized for or compatible with younger children under the age of 5. Aquillius Corporation proposes to develop a non-invasive respiratory sensor that is capable of real-time, continuous monitoring and measuring of pulmonary function to improve diagnosis, patient care, and outcomes for asthmatic youth.